Ultra-long-acting delivery for the prevention and treatment of HIV/AIDS

The applicant seeks this K99/R00 award to achieve research independence focused on the integration of
precision biomaterials and antiretroviral (ARV) therapy to innovate the treatment of HIV/AIDS. To achieve this
goal, the applicant will receive training in three critical areas: (1) design of long-acting injectables (LAIs) to
achieve sustained delivery of a broad spectrum of ARVs, (2) preclinical evaluation of LAIs in humanized HIV
mouse models, and (3) pharmacokinetic analysis and modeling.
She will receive guidance and comprehensive training through a detailed training plan from a mentoring team
of experts (Drs. Joshi, Barouch, and Karp) with an established track record of mentoring junior scientists to
independence. Her research will identify biodegradable LAIs that can provide sustained delivery of both
hydrophobic and hydrophilic ARVs for at least 6 months with minimal initial burst and rapidly achievable steady-
state plasma levels.
During the K99 phase, she will investigate how the physicochemical properties of her LAI and ARV hydrophilicity
can play a role in encapsulated ARV release and establish sustained prophylactic efficacy against HIV in a
humanized mouse model. She will also tailor the LAI formulations to deliver a broad spectrum of ARVs, enabling
single injection combination ARV therapy (cART) in vitro. This research goal, combined with the training and
mentorship she will receive, will prepare her for independence in the R00 phase. During the R00 phase, she will
utilize findings from the K99 phases for preclinical validation of sustained cART efficacy using her LAI in
humanized mice and PK analysis in non-human primates. Ultimately, this research aims to provide a strong
scientific rationale for future clinical trials, paving the way for a more accessible and effective approach to global
HIV prevention and treatment that promotes health equity.
Her findings during the K99 and R00 phases of this proposal will have a paradigm-shifting impact by providing
robust scientific justification for future clinical trials, paving the way for a more accessible and effective approach
to global HIV prevention and treatment, and promoting health equity. The K99/R00 award will thus provide the
applicant with a platform for an independent career using versatile ultra-long-acting drug delivery, the HIV animal
model, and human PK modeling to mitigate the HIV/AIDS epidemic.

Public health relevance
Currently, there is a lack of non-invasive extended drug delivery platforms capable of delivering both hydrophobic and hydrophilic HIV drugs in combination for more than 6 months, which hinders patient adherence. This K99/R00 proposal aims to bridge this gap by utilizing long-acting injectable (LAI) technologies that encapsulate a broad spectrum of antiretroviral (ARV) drugs. The goal is to provide sustained release of both hydrophobic and hydrophilic ARVs and to conduct a comprehensive preclinical evaluation that establishes the sustained efficacy of the LAI system.